VIDEO RECORDING OF FALLING IN THE ELDERLY

Falls and unsteadiness of gait are major problems faced by many elderly people. More than 150,000 hip fractures in elderly persons result from falls each year in the United Staes; the cost of these falls exceeds 1 billion dollars annually. With the exception of some studies of stairway accidents, we know of no actual recording of falls of elderly people. This lack of a clear objective record of the event has limited the ability of resarchers to determine factors worthy of study in order to most effectively contribute to prevention. A video recording system consisting of video cameras and videotape recorders controlled by a domestic microcomputer will be used to continuously record activity within the day care centre of a major geriatric centre. Whenever a fall occurs a member of staff will activate a single switch which will cause all of the tape drives to stop. The reearchers will then retrieve a record of the two hour period leading up to the fall. This record will be subjected to a detailed analysis which, it is anticipated, will provide new insight into the causes of falls and will provide information about postural control strategies used during a falling event. If such factors can be identifed, then measures to alter these factors may reduce the incidence of falling and the subsequent morbidity associated with the fall.